Rational Therapeutics for the Pediatric Population

DESCRIPTION: (PROVIDED BY APPLICANT): The Program on Health Outcomes (PHO) of the University of North Carolina at Chapel Hill seeks to perpetuate its UNC Center for Education and Research on Therapeutics (CERTs), the only CERTs to focus exclusively on safe, effective, rational therapeutic use for the pediatric population. Well aware of moral imperatives formally to study therapeutics in children so that they can enjoy equal access to all appropriate therapies, and the paucity of well-organized and accessible information about pediatric therapeutic use, the UNC CERTs commenced activity in September 1999. The present proposal is a competitive continuation application to extend core support for the UNC CERTs for 5 more years. The UNC CERTs-II goals are (1) to continue to maintain a core structure through which- multiple partnerships can achieve educational and research results that will change the behavior of health systems, providers, patients, and their families and influence health policy at the national, state, and local level; (2) to disseminate and, where possible, implement strategies to make pediatric therapeutic use safer; and (3) to achieve these goals across domains of better policy, more useful data, and more effective translations from research laboratory findings to rapid clinical applications. The original CERTs structure, with its great breadth and diversity, has served us well. Before the UNC CERTs began, no coherent, accessible entity devoted its attention to a comprehensive effort to improve pediatric therapeutic use through research and education. We seek to build on CERTs lessons in two ways: first, we present a new, diverse collection of projects that are more closely related to one another and that provide opportunities for (a) performing analyses not pursued aggressively in CERTs I, specifically including costs and cost-effectiveness, and attention to devices as well as to pharmaceuticals; (b) exploiting key databases and addressing as-yet unarticulated or late-breaking policy or practice issues; and (c) involving more young investigators in the CERTs work. Second, we will use the CERTs II mechanism to ensure that two pressing contemporary concerns changing practice behavior and influencing policymaking in the public and private sectors - are addressed specifically and intensely in the care of neonates, infants, toddlers, children and adolescents.